Administration Core

This is the administrative core for the Southeastern STI CRC (SE STI CRC), in which 6 projects and 3 cores are united under the general theme

Public health relevance
Core A provides administrative support for the Southeastern STI-CRC as required by the RFA.